Evaluation of a Ketogenic Diet for Improvement of Neurological Recovery in Individuals with Acute Spinal Cord Injury

ABSTRACT
Despite extensive research, clinical advancements, and improved rehabilitation strategies, spinal
cord injury (SCI) continues to be a significant cause of disability and mortality worldwide, and no
pharmacologic therapy has demonstrated significant improvement effects in the neurological or
functional recovery of individuals with SCI. Therefore, there is an urgent need for innovative
therapies for improving neurorecovery after SCI. The scientific premise of this project builds upon
accumulating evidence that diet-based therapies, such as the ketogenic diet (KD), offer effective
neuroprotection against secondary injury cascades and improve forelimb motor function in a rat
model of SCI. The KD is a high-fat, low-carbohydrate diet designed to mimic the metabolic and
biochemical changes that occur during calorie restriction, specifically ketosis. Ketone bodies have
been shown to exert neuroprotective effects by attenuating neuroinflammation and inhibiting
apoptosis in the spinal cord. Because neuroinflammation and induction of apoptotic pathways
lead to progressive degeneration in the spinal cord shortly after the injury, inhibition of these
processes by ketone bodies may enhance neurological recovery after an SCI. Indeed, our recent
pilot study showed for the first time that, compared with a standard hospital diet (SD), 5 weeks of
KD improved upper extremity motor function in patients with acute SCI. In addition, levels of a
neuroinflammatory blood protein, fibrinogen, were lower in the KD serum samples than in the SD
serum samples, suggesting a KD may induce anti-inflammatory effects in part by reducing
fibrinogen. The acute stage after SCI is also characterized by hyperglycemia, which is strongly
associated with poor functional outcomes at discharge. In our pilot study, fasting serum glucose
levels decreased by 24 mg/dl in the KD group but increased by 0.7 mg/dl in the SD group. These
provocative findings have led us to our central hypothesis that SCI patients who consume a KD
over the first 5 weeks (average hospital stay) after injury will have better neurological recovery,
functional independence, and glycemic control than the SCI patients who consume an SD during
this period. We will test this hypothesis in a randomized, controlled trial with two specific aims: 1)
Determine if 5 weeks of KD vs. SD significantly improves motor and sensory function, functional
independence, and glycemic control in patients with acute SCI, and 2) Quantify serum biomarkers
that are responsible for improvements in neurological recovery and functional independence. Our
findings will uncover the molecular mechanisms by which targeted nutritional strategies can
promote neurorecovery shortly after SCI and may lead to a safe, effective, simple, and economical
intervention that improves health outcomes after SCI.

Public health relevance
NARRATIVE Despite extensive research, no pharmacologic therapy has demonstrated significant improvement effects in the neurological or functional recovery in people with spinal cord injury (SCI), and the need for innovative therapies remains urgent. On the basis of preliminary data in rodents and patients, we have designed a randomized, controlled trial to examine the effects of a novel nutritional intervention, the ketogenic diet, on improving sensory and motor recovery, functional independence, and glycemic control in patients with acute SCI and on the molecular mechanisms thereof. Our findings may lead to a safe, effective, simple, and economical intervention that improves health outcomes for these patients.